Understanding the role of vagal FFAR3 in regulating glucose homeostasis

PROJECT SUMMARY/ABSRACT
The goal of this F31 application is to elucidate the roles and mechanisms of FFAR3 signaling in the vagus nerve in regulating
glucose homeostasis. Proper regulation of energy metabolism requires sensing of nutrient and hormonal cues to coordinate
an appropriate behavioral and physiological response. Vagus nerve sensing of dietary nutrients or nutrient-stimulated
hormones has been demonstrated to regulate food intake, glucose homeostasis, and gut motility. The gut microbiome
ferments soluble non-digestible fiber to release short-chain fatty acids (SCFA’s) which can serve as signaling molecules
through G-protein coupled receptors. The SCFA’s, including acetate, propionate, and butyrate can bind free fatty acid
receptor 2 (FFAR2) and 3 (FFAR3). Increasing dietary fiber intake or directly supplementing SCFA’s has been shown to
improve host glucose homeostasis, but the molecular mechanisms mediating these effects are unclear. Direct vagal sensing
of gut microbiome produced SCFA’s via FFAR3 could contribute to regulation of glucose metabolism. We found that
propionate was decreased in the plasma of western diet (WD)-fed mice compared to normal chow (NC)-fed controls. When
obese mice received oral gavages of fecal microbiome transplantations (FMT) from lean NC-fed donors, their plasma
propionate levels increased, and fasting blood glucose decreased. Directly supplementing propionate in the water of WD-
fed mice lowered fasting glucose and improved glucose tolerance. Propionate is the most potent known endogenous ligand
for FFAR3, and FFAR3 KO mice exhibit disrupted glucose tolerance, so we hypothesized that FFAR3 expressed on the
vagus nerve connects microbiome-produced propionate and central nervous system control of glucose homeostasis. Indeed,
we found Ffar3 to be actively translated in vagal sensory neurons. Treatment of vagal cultures with the FFAR3 ligand,
propionate, activated the neurons and increased neuronal translation of Glp1r. Vagal GLP1R function and expression is
dysregulated in rodent models of obesity, but the molecular mechanisms are not well understood. We hypothesize that
propionate signals through FFAR3 in the vagus nerve to increase Glp1r expression and improve glucose homeostasis. We
will test this hypothesis through the following aims. Aim 1 will assess if propionate activates vagal neurons and increases
Glp1r translation via FFAR3 in vagal organotypic cultures. We will accomplish this by utilizing the ribotag genetic mouse
model which allows for cell-specific assessment of genes in translation. We will assess translation of glucoregulatory genes
after propionate stimulation in vagal ganglia expressing FFAR3, and ganglia from FFAR3KO mice. Aim 2 will assess
whether vagal FFAR3 is required for propionate to improve glucose intolerance in vivo in WD-fed male and female mice.
To accomplish this, we will utilize a novel FFAR3 floxed mouse model and genetically ablate FFAR3 only from vagal
neurons. We will challenge control and vagal FFAR3KO mice with a western diet, supplemented with either saline or
propionate, to determine if propionate improves WD-induced glucose intolerance via FFAR3. Overall, we expect this study
to improve the understanding of how propionate and FFAR3 contribute to autonomic control of glucose homeostasis and
energy balance. The proposed study will elucidate new signaling pathways for the treatment of type 2 diabetes.

Public health relevance
PROJECT NARRATIVE Dramatic changes in lifestyle and diet in the recent years has led to a massive rise in Obesity and Diabetes. Gut bacteria ferment indigestible fiber to produce short-chain fatty acids (SCFA’s), which can signal via free fatty acid receptor 3 (FFAR3) on the vagus nerve and this may improve central nervous system control of blood glucose. More mechanistic studies are required to better understand the interaction between gut microbiome-produced metabolites and vagal control of glucose homeostasis.